Adrenergic transmission properties and implication

PROJECT SUMMARY
Norepinephrine (NE) and epinephrine (Epi) have been implicated in complex cognitive functions,
such as sensory processing, sleep-wake/arousal state transition and attention, in the brain, and other
biological processes in various tissues and organs, including the heart, pancreas and spleen.
Dysregulation of adrenergic transmission is linked to a number of neurological diseases, including
Alzheimer’s disease, depressive disorders and schizophrenia, as well as many other health problems,
including cardiovascular diseases, immune-deficiency and tumorigenesis.
Despite the potential involvement of NE/Epi in myriad physiological and pathological conditions,
the precise regulation and exact functional role of adrenergic transmission remain poorly defined, due
primarily to limitations of available tools for monitoring NE/Epi. We have recently developed a family
of intensity-based G-protein-coupled receptor (GPCR) activation-based genetically encoded NE
(GRABNE) sensors by coupling a circular permutated green fluorescent protein (cpGFP) with a human
adrenergic receptor. While these GRABNE sensors allowed the first visualization of adrenergic
transmission, the sensors were suboptimal in determining synaptic properties of adrenergic
transmission. To facilitate NE/Epi research, we recently engineered high-performance GRABNE
sensors that allowed high-sensitivity and high-resolution visualization of adrenergic transmission events
at single release sites. The new sensors and preliminary data build up our confidence to test the
hypothesis that high-performance GRABNE sensors may resolve the adrenergic transmission
properties that could deduce the adrenergic functional role. This application follows two specific
aims: Aim 1 is to determine whether high-performance GRABNE sensors may resolve adrenergic
transmission properties, and Aim 2 is to test whether adrenergic transmission plays an essential role in
the precision- and attention-demanding behaviors. We expect the proposed experiments to
characterize the first set of fundamental synaptic properties of a new form of neuronal transmission and
define a novel, unique functional role for adrenergic transmission.

Public health relevance
PROJECT NARRATIVE Despite the significance of neurotransmitters norepinephrine (NE) and epinephrine (Epi) in a large number of physiological and pathological conditions, adrenergic transmission remains poorly understood, due primarily to limitations of available tools for monitoring NE/Epi. We propose to employ our newly developed high-performance GRABNE sensors (and sensor-based superresolution and deconvolution microscopic analysis algorithms) to define the unusual synaptic properties and functional role for adrenergic transmission, and thus build the baseline for the future translational and clinical NE research.